The CHARMED model: a multimorbidity simulation model for people aging with HIV

PROJECT SUMMARY
Almost half of all people diagnosed with HIV in the United States are aged 50 or older and are at increased risk
for dementia and multimorbidity. Dementia is of major clinical policy concern because it results in inexorable
clinical decline and extremely high costs of care. People with HIV are at particularly high risk because they
often have major risk factors for the development of traditional etiologies of dementia, such as Alzheimer’s
Disease and Alzheimer’s Disease-Related Dementias (AD/ADRD), and they also have a risk of HIV-associated
neurocognitive disease (HAND) despite sustained virologic suppression. Depression, cardiovascular disease
(CVD), and HIV are known to have potent synergies that contribute to the development of dementia. These
comorbidities are modifiable risk factors for dementia that are highly prevalent, known to be undertreated in
people with HIV, and likely to be clinically and economically important for prevention and management.
The overall goal of this proposal is to provide an evidence-based approach for prioritizing and advocating for
interventions to improve the quality of life and reduce morbidity and mortality among people aging with HIV.
The benefits of reducing the burden of depression and CVD among people with HIV may currently be
underestimated, given that concomitant benefits related to multimorbidity are often not captured due to short
durations of observational or trial data. Determining which interventions are most clinically effective and cost-
effective is critically important to understand so that people aging with HIV can benefit from strategies to
reduce their risk of dementia and multimorbidity as they age. We propose to: 1) develop the Cognitive
impairment, HIV, Aging, heaRt, MEntal health, and Dementia (CHARMED) Model, including populating the
model with clinical and outcomes data from the North American AIDS Cohort Collaboration on Research and
Design (NA-ACCORD) and nationally-representative cost data; 2) project clinical and economic outcomes of
people aging with HIV; and 3) perform cost-effectiveness analyses of targeted interventions to reduce the
burden of depression and CVD and to quantify the resultant reduction in dementia and multimorbidity.
In this supplement, we outline the development of the HIV/Aging Internship Program: unique, paid internship
opportunities for high school and undergraduate students from backgrounds underrepresented in Medicine and
Public Health (URiM/URiPH). We propose internships in two areas of focus: 1) Research Methods, and 2)
Research Administration. In the Research Methods internship, each student will be paired with an investigator
(MD or PhD) with a focused research question. In the Research Administration internship, each student will
experience training opportunities with multiple mentors, including: program management, clinical research
coordination, and primary investigation. All research projects will be within scope of the funded parent grant;
the upfront investment from the one-year supplement will allow for the development of a program that is
sustainable for the future.

Public health relevance
PROJECT NARRATIVE Almost half of all people diagnosed with HIV in the United States are older than 50 years and are expected to live near normal life expectancies given effective antiretroviral therapy; however, people aging with HIV are at increased risk for dementia, depression, and cardiovascular disease. The overall goal of this project is to investigate the long-term clinical and economic consequences of different strategies to reduce dementia and multimorbidity among people aging with HIV. In this supplement, we propose to: 1) build on a strong track record of mentorship and supportive environment for trainees from backgrounds underrepresented in Medicine and Public Health (URiM/URiPH); 2) expand mentor training to learn best practices for mentoring trainees from a diversity of backgrounds; 3) cultivate strong relationships with local high schools and community colleges, and 4) develop a sustainable internship program for local high school students and college undergraduates who self-identify as URiM/URiPH.